Research Education Component

ABSTRACT: RESEARCH EDUCATION COMPONENT
Preventing and effectively treating Alzheimer’s disease and related dementias (ADRD) will require
increasing the number of gifted hands and minds from diverse backgrounds who are passionate about ADRD
research, and this is the mission of the Research Education Component (REC) of the UAB ADRC. Because of
the breadth and expertise of its large, diverse, and cohesive scientific community, UAB is uniquely positioned
to address Deep South disparities in dementia by training a diverse group of future leaders engaged in ADRD
research. The REC will leverage significant infrastructure already in place at UAB, including collaborations with
the Deep South Resource Center for Minority Aging Research (RCMAR), to achieve goals related to our focus
on Deep South disparities in dementia. The purpose of the UAB ADRC REC is to build research capacity on
Deep South disparities in dementia. We will expand the ADRD workforce by mentoring a diverse group of
scholars with the necessary intellectual and technical competences to bring together basic science and clinical
collaborations that will improve the lives of dementia patients. Launching Excellent Alzheimer’s Disease
Research Scholars (LEADRS) is our REC Scholars program and has two parallel pathways. The REC Trainee
track includes graduate students and early postdocs and the REC Investigator track includes late-stage
postdocs and junior faculty. Support provided to each is different and specific to the needs of the two groups.
We will develop a broad-based curriculum to support engagement with the UAB ADRC and REC scholars and
provide mentorship and research navigation to UAB investigators new to ADRD. The impact of the REC on the
UAB ADRC will be measured yearly, by the quality and impact of the research conducted by affiliated trainees
and the overall potential impact their research has on society. The major thematic goals of the UAB REC are to
increase diversity, collaborate to support trainees and scholars, and offer an array of programming that
promotes engagement with the UAB ADRC and enhances ADRD research across the UAB community.